Expressive Writing to Reduce Depressive and Anxiety Symptoms Among Sexual Minority Veterans

Sexual minority Veterans (e.g., gay, lesbian, bisexual) are one of the highest risk populations for psychiatric
disorders due in part to the experience of discrimination and stigma-based stressors (sexual minority
stressors). These stressors and the associated stress responses contribute to greater severity of depression
and anxiety, which confer risk for negative health outcomes (hazardous substance use and suicide). However,
very few interventions target distress related to sexual minority stressors, and even fewer have been tested in
Veteran Health Administration (VHA). Brief, easy to implement interventions that target distress related to
sexual minority stressors are needed to address the unique mental health concerns of this high risk community
of Veterans. Expressive writing is a brief, well-developed paradigm that involves writing about thoughts and
emotions related to a stressful experience for at least 15 minutes, 3-5 times based on a structured writing
prompt. Over 30 years of research supports expressive writing’s effectiveness in reducing stress, depression,
and anxiety related to a stressor. Expressive writing on a minority stressor (EWMS) has been shown to reduce
depression and anxiety among sexual minority non-Veterans but has never been tested among sexual minority
Veterans. The aim of the proposed study is to examine the feasibility, acceptability, and preliminary
effectiveness of EWMS, a promising intervention for sexual minority Veterans. Based on consultation with
experts in expressive writing and sexual minority Veteran health, EWMS will be adapted for sexual minority
Veterans and a VHA clinic setting. EWMS will be implemented as a 3 session, one-on-one intervention with a
therapist. The proposed EWMS protocol will be iteratively refined in a case series (n = 5), and then tested in a
pilot randomized control trial (RCT; n = 54) comparing EWMS to a neutral writing control condition. Aims of the
pilot RCT are: 1) demonstrate feasibility and acceptability of study procedures and EWMS; 2) examine the
preliminary effectiveness of EWMS relative to control in reducing depressive and anxiety symptom severity;
and 3) exploratory analyses will examine the preliminary effectiveness of EWMS relative to control in reducing
substance use (alcohol and drugs) quantity and frequency and suicidal ideation. The proposed research aims
are in direct alignment with the applicant’s short term and long term training goals. The proposed research and
complimentary mentorship and training plans will enable the applicant to: 1) gain expertise in intervention
adaptation and clinical trial research; 2) gain expertise in sexual minority health; 3) develop aptitude in
implementation theory and processes to inform future implementation of the proposed intervention and other
interventions; and 4) achieve career independence. The results of the pilot RCT along with the training and
mentorship of this project will inform a Merit award submission comparing EWMS with an active control in a
hybrid I implementation-effectiveness trial to test the efficacy of the intervention while collecting information on
barriers and facilitators to implementation of the intervention. This proposed research, training, and mentorship
plan will provide the applicant with the necessary skills and experience to transition into an independent clinical
researcher in VA focused on the development, enhancement, and implementation of interventions for minority-
related stress among sexual minority Veterans. The research and training will take place at the National Center
for Posttraumatic Stress Disorder at the VA Boston Healthcare System under the supportive, collaborative, and
accomplished mentorship team, including Drs. Brian Marx (primary mentor), Katherine Iverson (co-mentor),
and Nicholas Livingston (co-mentor). These mentors have unique, yet complimentary, areas of expertise and
have an established and successful history working together and with the applicant. The research, mentorship,
and training proposed will facilitate the applicant’s transition into a successful and productive independent VA
investigator conducting research that directly aligns with VA’s priority to provide equitable, patient-centered
services to Veterans.

Public health relevance
Sexual minority stressors (e.g., sexual minority identity-based discrimination) contribute to greater risk for and severity of depression, anxiety, substance use disorders and suicide among sexual minority Veterans. However, no brief, scalable, one-on-one interventions targeting sexual minority stressor-related distress are available in Veterans Affairs (VA) for sexual minority Veterans. The proposed research will examine the feasibility, acceptability, and preliminary effectiveness of a brief, 3-session expressive writing intervention to target distress related to sexual minority stressor exposure among sexual minority Veterans. The results of this work will advance knowledge about a promising brief and easy to implement intervention focused on reducing depressive and anxiety symptoms among sexual minority Veterans. This proposal aligns with VA’s and CSR&D’s commitment to providing equitable services to sexual minority Veterans and the aim of reducing health disparities among underserved Veteran groups.